Quantitative Ultrasound for Assessment of Placental Structure During the Development of Preeclampsia

PROJECT SUMMARY
A lack of effective treatments for preeclampsia persists due, in part, to our inability to detect altered placental
tissue microstructure as an indicator of abnormal placental development. This application proposes a MPI
collaborative study to be performed by Weill Cornell Medicine (WCM) in New York, NY and Tulane University
(TU) in New Orleans, LA. The proposed project is responsive to the Human Placenta Project PAR-22-236
and seeks to develop a novel ultrasound approach for “safe, real-time, and non-invasive” assessment of “the
development … of the human placenta across pregnancy”. Our long-term goal is to develop imaging tools to
improve outcomes in women with preeclampsia. The overall objective of this proposal is to develop and
validate quantitative ultrasound (QUS) to detect and correlate microstructural alterations in the placenta with
preeclampsia. QUS uses radio-frequency (RF) US signals to characterize soft tissues quantitatively. We
hypothesize that QUS-based parameters will be capable of quantifying the microstructural changes which
characterize preeclampsia. Guided by a strong scientific premise, this hypothesis will be tested by pursing
two specific aims: 1) To quantify altered human placental microstructure ex vivo; and 2) To assess placental
microstructure longitudinally in vivo in an established rodent model of preeclampsia. Under the first aim, we
will develop QUS methods to characterize the human placenta and test the hypothesis that specific QUS
parameters will correlate with altered vascular development and injury in the ex vivo human preeclamptic
placenta, with histopathology as the gold standard. The second aim will test the hypothesis that QUS
parameters will correlate with microstructural and changes due to altered vasculature and fibrosis in the
reduced uterine perfusion pressure rat model of preeclampsia. The expected outcome of this work will be
the validation of QUS-derived parameters for the assessment of placental microstructure. With these imaging
methods, we anticipate correlating specific QUS parameters related to placental microstructure with the
diagnosis of preeclampsia. This outcome will strongly motivate the dedication of additional resources for
clinical translation and in vivo longitudinal validation of QUS to earlier detect and predict severity of
preeclampsia in women. Consistent with the goals of this funding opportunity and the goals of the HPP, this
work will lead to the development of a new point-of-care ultrasound assessment of preeclampsia risk and
severity, which can be accomplished using the ultrasound systems existing in the clinic.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health since the development of in vivo imaging tools to assess placental functional response will improve the treatment of preeclampsia. The proposed research is relevant to the part of the NIH’s mission that pertains to research strategies to improve health, by reducing the maternal and fetal impacts of preeclampsia.